Adaptive Working Memory and Physical Exercise Training to Improve Brain and Mitochondrial Function in MCI

Project Summary
With the aging population, the prevalence of dementia will more than double in the next three decades in the
U.S. Globally, an estimated 75 million individuals will have dementia by 2030; caring for these individuals will
have a global cost of 2 trillion USD. According to the WHO, the increasing number of individuals with dementia
alone could overwhelm the global health care system and undermine social and economic development.
Therefore, effective treatment or prevention for dementia is urgently needed. Currently, no curative treatment for
dementia exists despite numerous clinical trials and research studies related to dementia. However, recent data
indicate that improved nutrition and physical activity might have contributed to the declined incidence of dementia
in the U.S. and in Europe. Hence, the current proposed project aims to evaluate the brain changes and some of
the possible underlying mechanisms associated with the combined adaptive working memory training and
progressive aerobic exercise training to improve brain function in healthy elderly and in those with mild cognitive
improvement (MCI). This project fits well within the goals of the National Alzheimer’s Plan of Action (NAPA),
especially with regards to “Prevent and Effectively Treat Alzheimer's Disease by 2025.”
The proposed administrative supplement fits well within the overarching University of Maryland Older Americans
Independence Center (UM-OAIC) goal which is to build on the sciences and therapeutic applications of exercise
and rehabilitation. Specifically, we propose the following two specific aims: Aim 1: To evaluate how the
combination of Cogmed® training and exercise training will improve brain structure (on structural MRI), brain
blood flow (on perfusion MRI) and on cognitive tests, both in MCI and non-MCI older adults. Study design: 18
individuals with MCI (age>50-80 years), who have higher risk for developing dementia or AD, will be compared
to 18 healthy individuals without cognitive deficits, of similar age range, race, sex proportions, and socioeconomic
status (SES), before and after a 3x/week x 16 weeks aerobic exercise program, along with an adaptive working
memory training program (Cogmed® 5x/week, 25 sessions/ over 5-8 weeks). Aim 2: To evaluate potential
mechanism(s) that might contribute to the improved brain structure, brain blood flow or cognition by studying
these changes with mitochondrial function / respiration in platelets, biomarkers for neurodegeneration in the
brain [NAA and glutamate on proton spectroscopy (1H MRS)] and in the periphery (plasma Aβ-40, Aβ-42, Tau,
NFL). Findings from this exploratory pilot project will provide the necessary preliminary data to refine and direct
a future larger trial (e.g., using a 2 x 2 design, with or without Cogmed® or exercise training, for the intervention(s)
in MCI subjects and controls) using these approaches.

Public health relevance
Project Narrative The prevalence of dementia will double in the next three decades in the U.S; effective treatment or prevention for dementia is urgently needed. The current exploratory project aims to evaluate and understand how the brain and cognition may improve after a 16-week intervention that combines brain training and aerobic exercise training to improve brain function, both in those with mild cognitive impairment (some with possible prodromal Alzheimer’s disease) and with healthy aging. Findings from this pilot project will guide and refine the development of a future larger clinical trial that aligns with the goals of the National Alzheimer’s Plan of Action (NAPA), especially with regards to “Prevent and Effectively Treat Alzheimer's Disease (AD) by 2025”.